NEUROCOGNITIVE FUNCTION, HIV LOAD &SURROGATE MARKERS

The objective of this study is to determine if HIV load (RNA copy number) or immune activation in plasma, or within CNS, are associated with, or predict, neurological decline.